Discerning the mechanisms of CYB5R1 regulation of ferroptosis in endothelial cells

PROJECT SUMMARY/ABSTRACT
This is an F31 application from Robert Hall, who is a predoctoral student in the Department of Pharmacology
and Chemical Biology at University of Pittsburgh School of Medicine, under the mentorship of Drs. Adam Straub
and Patrick Pagano. This project focuses on ferroptosis, an iron-dependent form of cell death initiated by
intracellular iron (Fe2+) accumulation and elevated hydrogen peroxide (H2O2) levels, which leads to
polyunsaturated fatty acids (PUFAs) peroxidation and cell death. Emerging evidence supports the concept that
ferroptosis contributes to endothelial cell (EC) dysfunction and the development of several cardiovascular
diseases. However, the mechanisms modulating ferroptosis in ECs are not fully elucidated. The Straub lab
focuses on understanding the physiological and pathophysiological roles of cytochrome b5 reductase (CYB5R
1-5) enzymes in the cardiovascular system, which are proteins that govern redox balance. We recently
conducted a large-scale genomic screen comparing differences gene profiles from all five CYB5R enzymes
knocked down in primary human aortic endothelial cells (HAECs). Pathway analysis revealed that loss of
CYB5R1 increased ferroptosis-related genes. Preliminary studies demonstrates that CYB5R1 localizes to the
outer mitochondrial membrane and functions to mitigate the accumulation of ROS and lipid peroxides, ultimately
preventing ferroptosis. Based on our preliminary data we hypothesize than CYB5R1 protects endothelial cells
from ferroptotic cell death by mitigating membrane lipid peroxidation. We will test this hypothesis using two
specific aims. Aim 1 will determine the mechanism by which endothelial CYB5R1 modulates ferroptosis and
Aim 2 will determine whether loss of endothelial cell expressed CYB5R1 impacts blood vessel function. These
studies will help define a potential new role of CYB5R1 in endothelial cell function, with particular focus on
ferroptosis. Importantly, this project, coupled with didactic coursework, mentored training, and a customized
career development plan within an exceptional training environment at the University of Pittsburgh, will ultimately
provide the necessary skill sets needed to help foster the applicant’s long-term goal of a career in biomedical
research.

Public health relevance
PROJECT NARRATIVE This study seeks to determine the role of endothelial cell cytochrome b5 reductase 1 (CYB5R1) and its role in modulating ferroptosis. The outcomes of these studies may fill a major void in our understanding of the role of CYB5R1 in vascular physiology and disease, with the potential for the development of new strategies and therapeutics to reduce the burden of cardiovascular disease.